Partner Violence and Reproductive Coercion Among Native American Women

DESCRIPTION (provided by applicant): Unintended pregnancy confers significant adverse consequences for women, their children, and society, and is closely associated with intimate partner violence (IPV) and sexual assault (SA). Native American (NA) women are at particularly high risk for experiencing unintended pregnancy and IPV/SA. IPV confers risk for unintended pregnancy through multiple mechanisms including forced unprotected sex and compromised decision making regarding contraceptive use as well as through reproductive coercion - male partners promote pregnancy through threats and contraceptive sabotage. Studies have not included sufficient numbers of NA women to understand how IPV, reproductive coercion, pregnancy intentions, and contraceptive behaviors may differ from non-NA women. A family planning clinic-based brief safety card intervention has been shown to reduce reproductive coercion, and is being tested in a large cluster-randomized controlled trial to assess the impact on IPV and unintended pregnancy (1R01HD064407-01A1, PI Miller). However, in a pilot demonstration project funded by the Office on Women's Health with the Hoopa tribe in Northern California, health care providers and victim advocates identified limitations with this safety card for use with NA women on reservations including limited access to clinical and victim services, low levels of contraceptive use, and ambivalence around pregnancy. We propose to conduct a qualitative study with NA adolescent and adult women in three diverse tribal communities: the Hoopa tribe in Northern California, the tribal nations and pueblos of New Mexico, and the Maliseets and surrounding tribes in Maine. We propose to conduct one-on-one semi-structured interviews with NA adolescent and adult women ages 16 to 35 in these communities (N=60) to identify pathways connecting IPV, reproductive coercion, pregnancy intentions, contraceptive behaviors, and reproductive histories among NA women (Aim 1); to explore how cultural, structural, and relationship factors shape NA women's experiences with IPV, pregnancy, contraceptive use, and care seeking behaviors (Aim 2), and to test face and construct validity of existing survey items for assessing IPV, reproductive coercion and unintended pregnancy with NA adolescent and young adult women (Aim 3). To date, no studies have examined NA women's experiences with reproductive coercion, IPV/SA, and unintended pregnancy. This study will help clarify how NA adolescent and adult women describe pregnancy intention and contraceptive behavior, and the cultural, structural, and relationship factors including violence which affect their intentions and behaviors. This study will advance our understanding of the relationships among unintended pregnancy, violence, race and contraceptive decision making while simultaneously pinpointing targets for intervention. This study will lay the groundwork for an R01 to adapt and test a brief intervention designed to help NA women connect their relationship experiences with pregnancy intentions, promote effective contraceptive use, and reduce IPV and unintended pregnancy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Unintended pregnancy confers significant adverse consequences for women, their children, and society, and is closely associated with intimate partner violence (IPV), sexual assault (SA), and reproductive coercion (male partners promote pregnancy through threats and contraceptive sabotage). Native American (NA) women are at particularly high risk for experiencing unintended pregnancy and IPV/SA, yet to date, no studies have examined NA women's experiences with IPV/SA, reproductive coercion, and unintended pregnancy. This qualitative study will clarify how NA adolescent and adult women describe pregnancy intention and contraceptive behavior, and the cultural, structural, and relationship factors including violence and reproductive coercion which affect their reproductive decision making, to lay the groundwork for a randomized clinical trial to test a brief intervention designed to help NA women connect their relationship experiences with pregnancy intentions, promote effective contraceptive use, and reduce IPV and unintended pregnancy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Unintended pregnancy confers significant adverse consequences for women, their children, and society,1-4 and is closely associated with intimate partner violence (IPV) and sexual assault (SA).5-11 Native American (NA) women are at particularly high risk for experiencing unintended pregnancy12,13 and IPV/SA.14-17 As many as two thirds of pregnancies among NA women are unintended compared to 40% of pregnancies among white women.12,18 The estimated lifetime prevalence of IPV/SA ranges from 44% to 70% among NA women, about 1.3 to two times greater than white women. 14,15,19-22 IPV confers risk for unintended pregnancy through multiple mechanisms including forced unprotected sex, and compromised decision making regarding contraceptive use.23-28 Miller's (PI) research team has identified an additional mechanism connecting IPV with unintended pregnancy -- reproductive coercion. Abusive male partners actively promote pregnancy via behaviors spanning verbal pressure to become pregnant, threats or actual violence in response to condom requests, and direct acts of contraceptive sabotage.8,29-32 Twenty five percent of participants in our pilot study in California had experienced reproductive coercion.30 Studies on reproductive coercion have not included sufficient numbers of NA women to understand how IPV, reproductive coercion, pregnancy intentions, and contraceptive behaviors may differ from non-NA women. A family planning clinic-based brief safety card intervention has been shown to reduce reproductive coercion,33 and is currently being tested in a large cluster-randomized controlled trial to assess the impact on IPV and unintended pregnancy (1R01HD064407-01A1, PI Miller). However, in a pilot demonstration project funded by the Office on Women's Health with the Hoopa tribe in Northern California (OWH - ASTWH 090016-01-00), health care providers and victim advocates identified limitations with this safety card for use with NA women on reservations including limited access to clinical and victim services, low levels of contraceptive use, and ambivalence around pregnancy. We propose to conduct a qualitative study with NA adolescent and adult women in three diverse tribal communities: the Hoopa tribe in Northern California, the tribal nations and pueblos of New Mexico, and the Maliseets and surrounding tribes in Maine. The focus will be on NA women living on reservations who are at particularly high risk for unintended pregnancy and where access to services is limited to gain insight about experiences of IPV/SA and the intersection of such violence with their reproductive histories. We will conduct one-on-one interviews to deepen our understanding of the impact of IPV/SA on pregnancy intention and contraceptive behavior in the context of limited services, Native histories of oppression, and mistrust of the health care and criminal justice systems. Additionally, women will be asked to complete a brief computerized survey about their pregnancy history, history of IPV, and experiences of reproductive coercion. Examination of how cultural factors impact pregnancy intentions and reproductive health behaviors requires consideration of an array of sociocultural issues including reproductive autonomy, partner influences, and social norms related to contraception, pregnancy, and interpersonal violence. Qualitative research can help elucidate which of these issues are particularly salient and the mechanisms through which they lead to unintended pregnancy to guide culturally relevant interventions to reduce violence victimization and unintended pregnancy for NA women. Innovation: NA women bear a disproportionate burden of unintended pregnancy and IPV, but research-tested interventions to address this nexus of IPV and poor reproductive health that are culturally relevant are woefully missing. Developing harm reduction interventions effective in the context of social disadvantage is critical to reducing violence and promoting reproductive health for marginalized populations. Impact: The brief safety card intervention in the family planning clinic setting demonstrated over 70% reduction in pregnancy coercion risk among women experiencing recent IPV.33 The findings from this qualitative study are expected to translate directly into adaptation of this brief intervention for use in health care settings serving NA women with the goal of reducing unintended pregnancy and IPV. Aim 1: To identify pathways connecting IPV/SA, reproductive coercion, pregnancy intentions, contraceptive behaviors, and reproductive histories among NA adolescent and adult women in three diverse communities (ages 16-35, N = 60 interviews). Aim 2: To explore how cultural, structural, and relationship factors shape NA women's experiences with IPV/SA, pregnancy, contraceptive use, and care seeking behaviors. Aim 3: To examine face and construct validity of existing survey items assessing IPV/SA, reproductive coercion, and unintended pregnancy with NA adolescent and young adult women. This community-partnered study will lay the groundwork for an R01 to adapt and test a brief intervention designed to help NA women connect their relationship experiences with pregnancy intentions, promote effective contraceptive use, and reduce IPV and unintended pregnancy.